HUMANIZED ANTI-IL 2 RECEPTOR ANTIBODIES TO TREAT AUTOIMMUNE UVEORETINITIS

Experimental autoimmune uveoretinitis (EAU) in primates, an animal model for uveitis in humans, was further used in FY 1996 to test the efficacy of the humanized anti-interleukin 2 (IL-2) antibody BG-5 and the cytokine IL-13 in the treatment of inflammatory eye diseases. Uveitis was induced in cynomolgus monkeys by immunization with human recombinant retinal S-antigen in Hunter's adjuvant. Treatment was initiated at the first sign of disease and consisted of BG-5 given by intravenous injection twice a week, recombinant murine IL-13 given by subcutaneous injection once a day, or vehicle control administered for a period of 4 weeks. Disease was evaluated by funduscopy twice a week for 56 days. BG-5 treatment had only a slight effect on disease outcome. In contrast, EAU evolution was significantly improved by IL-13 treatment. These data thus suggest that IL-13 could be considered as a future treatment for uveitis.